Ultrasound image-guided treatment of ischemia-reperfusion injury using argon microbubbles

The key health significance of this proposal involves the ultrasound-mediated, image-guided, localized treatment
of ischemia reperfusion injury (IRI) in neuronal and cardiac models using echogenic argon microbubbles
(ArMBs). There exist no clinically approved methods for treating damaged tissue after experiencing hypoxic
ischemic and reperfusion injuries such as stroke or cardiac arrest. Noble gases like argon (Ar) and xenon (Xe)
are highly promising cytoprotective agents that have been shown to successfully treat acute IRI in vitro and in
animal models. Whereas Xe has been researched in greater detail including in early clinical trials, it can be
prohibitively expensive and difficult to obtain. Ar is a hundred times cheaper and widely available, while exhibiting
excellent organoprotective efficiency. Furthermore, the mechanism of Xe action depends on its interaction with
glutamate receptors on cell membranes, whereas Ar is reported to work by stimulating various endogenous
cellular protecting signaling pathways, making it a more versatile antiapoptotic agent. Current Ar therapy is long
and systemic, via inhalation, making it non-specific to the injury site, likely diminishing therapeutic effect. As a
solution, we propose the development of MBs (MBs) for localized delivery of the therapeutic gas. MBs are
inherently echogenic due to their non-linear oscillations induced by clinical ultrasound. Therapeutic gases such
as Ar, however, are difficult to stabilize inside bubbles due to the former's high aqueous solubility. The team has
recently succeeded in small-scale production of stable, echogenic, noble gas MBs through optimization of the
MB shell composition, leading to a productive, ongoing collaboration with clinicians at the Children's Hospital of
Philadelphia (CHOP). The proposed research will be conducted through the implementation of three specific
aims. (1) 1-10 µm ArMBs will be formulated at a high yield of >1010 MBs per mL. Ultrasound signal of optimized
ArMBs will be investigated in flow phantoms and in a mouse model by measuring the magnitude, perfusion, and
persistence of contrast. (2) The therapeutic effect of ultrasound mediated Ar release from bubbles in treating IRI
will be estimated in in vitro cell culture-based simulations of neuronal and cardiac injuries induced by oxygen
glucose deprivation. The validity of ArMBs will be proved by enhanced cell viability, decrease in caspase
activation, and upregulation in the phosphatidylinositol 3 kinase (PI3K-AKT) pathway. (3) Further incentive to
use ArMBs will be recognized by comparing their IRI treatment results to that of bulk Ar exposure to cells and
exposure to XeMBs. ArMB activity even with the deactivation of glutamate receptors will be shown to cement
the feasibility of ArMBs for a variety of cytoprotective treatments. The PI team will leverage their expertise in
colloidal design, cellular dynamics, and ultrasound imaging to precisely engineer the ArMB shell and to rigorously
establish the validity of this new, inexpensive agent in vitro for the team's long-term goal of testing ArMBs for
non-invasive, image guided treatment of IRI in large animal models and translating them to clinical settings.

Public health relevance
Ischemia reperfusion injuries (IRI) occur commonly following stroke, myocardial infarction, and cardiac arrest causing thousands of fatalities and even more disabilities globally, with there being no clinically approved methods for treating tissue damage inflicted by post-ischemic injury. The current proposal aims to use argon as a cytoprotectant by developing stable, echogenic microbubbles to enable ultrasound mediated, localized, image- guided delivery of the therapeutic gas at the injury site. Validation of the therapeutic effect of argon microbubbles in in vitro simulations of IRI will pave the way for an inexpensive and non-invasive treatment method suitable for easy bedside translation and operating protocols.